Low Latency Eye-Motion Compensation

PROJECT SUMMARY
Adaptive optics (AO) scanning ophthalmoscopy allows non-invasive visualization of microscopic retinal
structures by correcting the optical blur that is unique to each eye. In these instruments, however, image
distortion due to involuntary fixational eye movement is a barrier to improving the understanding, early
diagnosing, and management of eye disease. We propose to develop high-bandwidth eye motion stabilization
technology and image registration software to mitigate this distortion even in subjects with the most extreme
forms of involuntary eye motion, including nystagmus. This will be achieved by using a high frame rate pupil
tracker that measures the eye’s orientation and by steering galvanometric optical scanners to simultaneously
stabilize the view of the pupil and the retina as seen by AO scanning ophthalmoscopes with sub-millisecond total
latency. Our goal here is to develop low-cost, low-complexity, and high-bandwidth retinal imaging stabilization
instrumentation that can be used to upgrade both AO and non-AO ophthalmoscopes, using control algorithms
that incorporate eye motion prediction, electronic and mechanical latency. Finally, we will also develop image
registration software for scanning ophthalmoscopes that uses the high frame rate pupil tracking to improve
accuracy and reduce failure rate, as well as automate the identification of and un-distort reference frames. The
proposed technology will be applicable to all scanning ophthalmoscopes, irrespective of imaging modality.

Public health relevance
PROJECT NARRATIVE Retinal images captured with adaptive optics scanning ophthalmoscopes are severely distorted due to constant involuntary eye movement. In this project, we propose to develop low-cost high-speed instrumentation and software to compensate for this movement to improve the understanding, diagnosing, and management of eye diseases.